Accelerating Open Science through Enhanced Access to Catalogs of Metadata Templates

Project Summary
The proposed project aims to enhance Stanford’s CEDAR platform for creating and managing metadata in
scientific research, ensuring that datasets are Findable, Accessible, Interoperable, and Reusable (FAIR).
CEDAR enables the use of metadata templates that render community-based reporting guidelines, simplifying
the creation of standardized data records for users. As adoption by NIH projects continues to grow, there is a
need to customize CEDAR to address the specific requirements of diverse user communities. Additionally, with
the increasing number of submissions, it is essential to organize the repository’s contents in a structured and
domain-specific manner to enhance searchability for domain experts. These improvements will make CEDAR
more adaptable and user-friendly, supporting the varied needs of the scientific community and facilitating more
efficient data management and discovery.
The two primary goals include:
1. User Profiles: CEDAR will introduce three distinct user profiles to cater to the diverse needs and
purposes of different user communities:
a. Basic Profile: Designed for use cases where metadata consists of simple attribute-value pairs
with straightforward input constraints for data validation purposes. This profile facilitates easy
and efficient creation of standardized metadata without requiring specialized technical
knowledge.
b. Semantic Profile: Building on the Basic Profile, the Semantic Profile enables interoperability
with BioPortal. This allows metadata values to be linked to standardized terms in biomedical
ontologies, ensuring that users can specify the meanings of metadata values unambiguously
and consistently.
c. Modular Profile: Intended for use cases where metadata structures are shared across multiple
projects and need to be organized into granular, reusable components. The Modular Profile
supports intricate metadata arrangements, promoting consistency and reusability in
collaborative and large-scale research environments.
2. Enhanced Search and Cataloging: CEDAR will provide a structured catalog of metadata templates,
systematically organized using terms from standard biomedical ontologies. This organization will enable
users to locate templates relevant to their specific domains efficiently. By leveraging semantic
relationships, the structured catalog will significantly enhance the discoverability of templates,
facilitating their use by biomedical investigators who wish to ensure that their datasets are FAIR.

Public health relevance
Project Narrative When investigators create standardized descriptions of their scientific datasets (known as metadata), third parties can search for the datasets in online repositories, reanalyze the data, verify the results, and even make new discoveries. Computer technology known as the CEDAR Workbench provides a means to create standard metadata for describing datasets and to manage those metadata in an online library. In this software- engineering project, we will make it easier for scientists with different degrees of computer expertise to create machine-actionable metadata descriptions and to search for them in a comprehensive library that is shared among whole communities of investigators.